Outreach, Recruitment, and Engagement Core

(ADRD); however, incidence, prevalence, risk factors, and clinical features can vary by race and ethnicity.
Evaluating and addressing these disparities is urgent since non-Caucasian racial or ethnic groups will make up
45% of Americans ages 65+ by the year 2060. Ensuring recruitment of appropriately diverse research
participants is a formidable challenge, and ADRD studies often lag behind such goals. These shortfalls are
likely due to a confluence of barriers, including “research readiness” of target populations, lack of ADRD
knowledge, and associated stigma. In the Outreach Recruitment and Engagement (ORE) Core, we apply
innovative strategies to achieve three overarching goals centered on (1) recruiting and retaining a well-defined
cohort of research participants; (2) serving as the primary regional resource for consumable, accurate, and
culturally-informed information on ADRD diagnosis, management, and research opportunities; and (3)
increasing research readiness of underrepresented groups (URGs) through evidence- and experienced-based
outreach and education. We share ADRD educational information and resources via our website
(www.uwadrc.org), bi-annual magazine Dimensions, and monthly e-Newsletter. At the University of
Washington Alzheimer’s Disease Research Center, we have a special focus on American Indian / Alaska
Native (AI/AN) engagement, a historically gravely overlooked URG in ADRD research efforts. Through a highly
successful collaboration with Partnerships for Native Health (P4NH) at Washington State University, we will
continue to improve research readiness among AI/AN elders, with emphasis on promoting brain donation. We
will expand these efforts to other URGs in order to engage the local communities of color. We emphasize
respectful, bidirectional relationships with our community partners while conducting the most rigorous science
aligned with their priorities and comfort with research. We operate on the model of knowledge exchange, and
advocate a strength-based reframing perspective to counter stigma by emphasizing social and cognitive
functions that are spared in ADRD.